Transdiagnostic and Disorder-Specific Effects of Immune and Metabolic Factors on Motivational Deficits Across Mood and Psychotic Disorders

PROJECT SUMMARY Symptoms related to low motivation are common to many psychiatric disorders, particularly mood and schizophrenia spectrum disorders. These motivational deficits have been associated with elevated inflammatory markers across these disorders. Significant clinical and preclinical data indicate that effects of inflammatory mediators on dopamine (DA) in the ventral striatum may mediate the association between inflammation and decreased motivated behavior. In a related fashion, increased inflammation is associated with a shift in immunometabolism away from the more energy efficient oxidative phosphorylation to the relatively inefficient aerobic glycolysis. This shift in metabolism significantly depletes available energy resources that may be communicated to the brain through effects of inflammatory mediators on striatal DA in order to constrain motivation and conserve energy resources during periods of heightened immune activation. To date, however, it remains unknown whether these striatal DA-immune interactions represent a transdiagnostic mechanism for motivational deficits across different disorders. The focus of this proposal is to determine whether elevations in inflammation and related immunometabolic changes represent a common mechanism for impairments in motivation across disorders of psychosis and mood. Given that recruitment of a well-powered transdiagnostic sample would not be possible under an R21 mechanism, this proposal is uniquely poised to leverage data collected by R01MH066031 (PI: Barch) at Washington University. R01MH066031 is recruiting a transdiagnostic sample to assess behavioral and neuroimaging measures of motivation, including effort-based decision-making (EBDM) paradigms and ecological momentary assessment (EMA). The focus of the current proposal is to expand this project through the analysis of protein and genetic markers of immune activity and immunometabolism from this sample. Specifically, using blood samples collected from patients with unipolar depression, bipolar depression, schizophrenia, and schizoaffective disorder (n = 50 per group) as well as 75 healthy controls, elevations in inflammatory markers and their relationship to EBDM and EMA measures of motivation will be compared across groups (Aim 1). In Aim 2, we will assess different levels of gene expression within pathways of inflammation and immunometabolism and will relate changes to specific immune cell subsets using transcript-of-origin analyses. In particular, we will test whether enriched expression of genes in inflammatory pathways (e.g. NF-kB) and pathways related to glycolysis (e.g., insulin, MTOR, AKT, PI3K) localized within specific immune cells (e.g. monocytes) predicts reduced effort during EBDM and EMA measures. These data will help determine the extent to which potential immunotherapies, including anti-inflammatories and/or regulators of immunometabolism can confer disorder- specific or transdiagnostic benefits to patients with mood or schizophrenia spectrum disorders.

Public health relevance
Motivational deficits and elevated inflammatory markers have been widely reported across schizophrenia spectrum disorders and mood pathology (e.g., depression), and significant preclinical data exists to support a causal role for inflammatory mediators on motivated behavior. To date, however, it remains unknown whether these brain-immune interactions represent a transdiagnostic mechanism for different disorders. Using data collected by R01MH066031 (PI: Barch) at Washington University, this project will examine associations between inflammatory markers, gene expression, and behavioral, clinical and neuroimaging measures of motivational deficits in a large, transdiagnostic sample of patients with unipolar and bipolar depression, schizoaffective and schizophrenia disorders and healthy controls.